2024 Boston Bacterial Meeting (BBM)

Project Summary/Abstract
For 29 years, the annual Boston Bacterial Meeting (BBM) has brought together researchers involved in all
areas of bacteriology research, attracting attendees from both within and outside New England. In congruence
with its goal of cultivating the scientific and professional growth of young scientists, this long-standing meeting
is organized by student and postdoctoral fellow volunteers, with faculty and administrative support. BBM is a
two-day meeting featuring short oral presentations, multiple poster sessions, breakout sessions, evening
receptions, and a keynote lecture by a leading senior investigator. The participants typically hail from over 100
academic and biotechnology institutions and span both the breadth and depth of bacteriology research in the
New England area and increasingly beyond. Many participants attend BBM every year, recognizing it as a
unique, intellectually stimulating, and innovative conference.
BBM aims to (1) offer opportunities for young investigators to present their research, (2) provide a forum
for scientists to learn about and discuss new bacteriology research, and (3) foster collaboration and encourage
participants to build professional relationships. All research presentations at BBM are given by students,
postdoctoral fellows, and junior industry scientists. Thus, BBM promotes the careers of young scientists by
providing trainees and junior scientists a chance to hone their presentation skills and network with colleagues,
potential future advisors, and/or employers. Participants at BBM have expertise in disparate research fields
within basic systems, environmental, industrial, computational, and medical bacteriology, and presentations at
BBM reflect this scientific diversity. Unlike more topically focused conferences, BBM allows participants to hear
about and discuss a wide variety of discoveries and methods that may be unfamiliar but which all relate to the
common theme of increasing our understanding of bacteria. This feature, along with the geographical proximity
of most participants of BBM, enables the transfer of ideas, technology, and new discoveries between these
groups. To facilitate collaboration and building professional relationships, BBM includes multiple sessions for
free discussion as well as several opportunities for structured networking.
BBM will achieve its aims by continuing to cultivate a vibrant community of New England bacteriologists.
The meeting presents a broad range of topics and a format that encourages interaction among participants. For
many young researchers for whom attendance at major international meetings may not be financially feasible,
BBM is a vital opportunity to practice scientific communication and to be exposed to the rich bacteriological
research community that the conference draws upon. The emphasis on communication and interaction within
the broad scope of bacteriology is a major strength of the meeting. Overall, BBM has and continues to advance
research in basic, applied, and clinical microbiology, and furthers the professional development of attendees.

Public health relevance
Project Narrative The Boston Bacterial Meeting (BBM) brings together bacteriologists at varying career stages and from distinct subfields of bacteriology and provides an opportunity for them to meet, hear the latest research, discuss new ideas and methods, and initiate collaborations. BBM is especially important in that it specifically promotes the careers of young scientists by allowing them to present their own research, be introduced to work done across disparate fields of bacteriology, and by providing an opportunity for them to network in the local scientific community. By including basic scientists, healthcare professionals, and industry researchers, BBM helps disseminate recent work, and foster creative collaborations that produce new ideas for infectious disease treatment and prevention.